Leadership, Planning and Evaluation

Leadership, Planning, and Evaluation
ABSTRACT: The Sidney Kimmel Cancer Center (SKCC) utilizes a well-established system for Leadership,
Planning, and Evaluation efforts that engage Institutional Leaders, Senior Leaders, Program Leaders,
Shared Resources Directors, Cancer Center members and staff, advisors, and patient advocates. This
effort includes well-tested and integrated mechanisms to monitor, evaluate, and adjust the Center’s
Research Program activities, Shared Resources services, funding allocations, and strategic directions to
ensure alignment with SKCC vision and goals. Planning and Evaluation ensures that future directions are
achievable and that resources and investments are targeted effectively while providing the ability to respond
to new opportunities and changes in the cancer research field. Our Planning and Evaluation process is also
highly integrated with institutional planning and resource allocation activities to ensure alignment and ability
to capitalize on institutional investments.
Under Dr. Knudsen, leadership roles/structures, strategic and programmatic planning, and evaluation
processes have been transformed and have become embedded in our culture. We have instituted a multi-
year strategic plan that guides Leadership decisions and investments. Leadership has been increasingly
effective in defining and realizing the Cancer Center’s vision, using planning and evaluation mechanisms to
guide decisions, assess progress, and make changes to ensure success. In addition, the Executive
Committee now conducts intensive annual Program and Shared Resource reviews, through which they
carefully assess progress against milestones, future relevance, leadership, and future aims.
Senior Leadership serves to: 1) Establish a vision for the Center and oversee implementation of strategic
processes that ensure effective resource allocation, development and management of Programs, Shared
Resources, and other relevant components; 2) Foster a collaborative scientific environment that
facilitates high-impact research and clinical care; 3) Enable a focus on cancer problems applicable to the
catchment area served by the Center, informed by the TIPS (Transdisciplinary Integration of Population
Science) platform and senior leadership; and 4) Develop effective training and educational programs that
integrate the training of biomedical scientists and health care professionals.
Planning and Evaluation processes serve to: 1) Develop and oversee action plans that align with the SKCC
vision and mission to achieve Center goals; 2) Implement well-organized internal, external, and institutional
planning and evaluation processes that engage leaders, members, and advisors and enable the Center to
achieve goals; 3) Provide ongoing mechanisms to monitor, evaluate, and improve Programs, Shared
Resources, Developmental Funds, clinical research resources, new initiatives, funding priorities and
allocations, and strategic directions to ensure alignment with the Center’s vision and goals.